Faculty-Development

PROJECT SUMMARY: FACULTY DEVELOPMENT CORE
Transforming the environment to embrace inclusive excellence at an institution as large as the University of
Michigan (UM) requires innovative, evidence-based strategies. UM is well positioned to implement a program
to improve the success rates of underrepresented and/or minoritized (URM) scientists in securing faculty
positions and persisting in them, including via intentional hiring practices, rigorous programming and
strengthening mentoring networks and research support communities. The Michigan Program for Advancing
Cultural Transformation (M-PACT) will proactively implement scientifically informed interventions to support
careers of a talented, highly competitive and diverse group of M-PACT Scholars in the biomedical and health
sciences. These interventions will focus directly on Scholar development, as well as on the institutional actors
with whom Scholars interact and the academic environments in which Scholars operate to ensure impact
beyond the Scholars themselves. Specific Aims 1 and 2 focus on creating and cultivating high quality, culturally
engaged mentoring relationships, deep mentoring networks and supportive communities of practice. M-PACT
will provide intensive training around culturally engaged mentoring approaches to all program Sponsor-
Mentors, improving Scholars' and other faculty members' equitable access to high quality mentoring
relationships. M-PACT also will create topically focused subgroups, or research clusters, comprised of M-
PACT Scholars across schools/colleges, with clusters that span the spectrum of translational health research,
focused on: 1) Basic Biomedical Research; 2) Clinical-Translational Research; and 3) Social and Behavioral
Research. Led by expert faculty with strong records of mentoring URM early-career scientists, the clusters will
function as supportive and intellectually rigorous communities of practice, broadening and deepening Scholars'
mentoring networks of senior scientists and near-peer mentors and providing training, resources and other
professional development opportunities tailored to Scholars' specific research foci and disciplines/fields. Aim 3
focuses on career development around foundational skills relevant to Scholar productivity, success and
retention. A key focus will be to enhance M-PACT Scholars' preparedness and competitiveness for NIH R01
grants, addressing documented racial and gender disparities in access to external funding. Moreover, M-PACT
will support Scholars' skills and leadership for advancing DEI in the biomedical and health sciences in ways
matched to their career stage. Aim 4 emphasizes how M-PACT will support cultural transformation, including
and beyond the positive program impacts on the M-PACT Scholars, by 1) building institutional capacity and
buy-in through creating forums for sharing, exchange and action-planning with institutional and department
leaders and faculty around the use of evidence-based practices for improving mentoring and
campus/departmental climate; 2) creating communities and structures that promote belonging, skill-building
and productivity; and 3) increasing the persistence, success and retention of URM scientists.